Control of precisely timed gene expression during notochord development by Brachyury

PROJECT SUMMARY/ABSTRACT
Precise temporal regulation of stage-specific gene expression is fundamental for the proper
development of all organisms. Different molecular mechanisms that ensure the regionalized activation of gene
expression, such as activator gradients or localized transcriptional repressors, have been elucidated in
remarkable detail; however, the structural features of cis-regulatory sequences that enable transcription factors
to achieve the timely deployment of their downstream genes remain mostly unclear. The evolutionarily
conserved transcription factor Brachyury provides an example of a regulator that controls the spatial and
temporal expression of a large number of genes, many of which are required for the development of the
notochord. The notochord is the main feature shared by all chordate embryos, from tunicates to humans.
During the early embryogenesis of all chordates, the notochord provides support and patterning signals to the
developing body and is indispensable for patterning neural tube, endoderm, paraxial mesoderm, and the
structures that they will form.
In the tunicate Ciona, an invertebrate chordate, Brachyury is exclusively expressed in notochord cells,
where it controls the expression of hundreds of genes. Even though Ciona Brachyury (Ci-Bra) is steadily
transcribed and transported to the nuclei of the notochord cells throughout development, the genes
downstream of Ci-Bra exhibit a distinctive, temporally staggered onset. In an effort to identify the cis-regulatory
strategies responsible for the precise temporal regulation of notochord gene expression by Ci-Bra, we have
characterized several cis-regulatory regions (aka enhancers) that control the notochord expression of Ci-Bra-
downstream genes characterized by different temporal onsets. These studies have led us to formulate a
working hypothesis that explains how Brachyury controls its early-, middle- and late-onset target genes. This
hypothesis will be tested through the following experimental approaches: the elucidation of the cis-regulatory
principles underlying the sequential activation of early-onset and middle-onset notochord genes directly
controlled by Ci-Bra (Aim 1); the functional analysis of two transcription factors that activate expression of late-
onset notochord genes (Aim 2); the exploration of the role of transcriptional repressors in notochord
development (Aim 3).
These studies will shed light on the modalities employed by a pivotal transcription factor to set the
temporal context for developmental processes of widespread relevance, such as convergent extension and
extracellular matrix secretion, and will provide the mechanistic framework that is needed to diagnose and
prevent malformations and tumorigenesis associated with the multifaceted transcription factor Brachyury.

Public health relevance
PROJECT NARRATIVE The notochord is the main embryonic axial structure necessary for development and patterning of the body plan, and in humans impaired notochord formation can result in birth defects, vertebral malformations and bone- derived malignant tumors called chordomas. The transcription factor Brachyury is known to be indispensable for notochord development and to be an etiological agent of chordoma; however, it is still unclear how this transcription factor coordinates the temporal expression of all its numerous target genes, which in turn control different stages of notochord formation, and how Brachyury-downstream transcription factors allow Brachyury to control late-onset genes required for morphogenesis and differentiation of the notochord. The research proposed here will fill these gaps in knowledge by studying how temporal information is encoded in notochord cis-regulatory regions directly controlled by Brachyury, by reconstructing the gene batteries that are regulated by Brachyury-downstream transcription factors, and by elucidating how transcriptional repressors refine notochord gene expression.